A transformative drug discovery platform for allosteric kinase inhibitors

Project Summary
The University of Minnesota (UMN) and Photonic Pharma (PP) a Minnesota-based drug discovery start-up, have
partnered to optimize, field-test, and deploy at industrial scale, an innovative new approach to developing
allosteric kinase inhibitors (AKI). These molecules have high potential as novel cancer therapeutics that
circumvent clinical resistance to conventional orthosteric kinase inhibitors (OKI). We have developed high-
throughput screening (HTS) technology based on nanosecond fluorescence lifetime (FLT) detection of Förster
resonance energy transfer (FRET), that tracks ligand-driven kinase allostery with angstrom precision by
monitoring structural changes of the activation loop, the key regulatory element in all kinases. This is the first
HTS-amenable technology that accurately resolves allosteric effects of kinase inhibitors, relying on high-quality
nanosecond FLT readouts unavailable from conventional fluorescence plate readers (PR). PP have developed
a proprietary HTS platform that uses FRET biosensors and a state-of-the-art FLT-PR to detect structural
readouts in <2 min for 384-well and <5 min for 1536-well plates. By partnering with PP, we will transform our
kinase FRET sensor technology into a broadly applicable drug-discovery platform for identifying AKIs.
We propose drug-discovery programs on two different targets to demonstrate broad utility and accelerate large-
scale adoption of our technology for drug development. In AIM 1, we identify Aurora A inhibitors that
downregulate the undruggable c-Myc oncoprotein by inhibiting the scaffolding interaction of Aurora A with c-
Myc. These molecules would represent a novel treatment strategy for the large number of cancer patients with
c-Myc-driven tumors. In AIM 2, we identify allosteric inhibitors of the c-MET receptor tyrosine kinase as a novel
therapeutic strategy for patients with c-MET-driven lung cancer. These patients invariably develop resistance to
current MET inhibitors through acquired mutations in the ATP site, and allosteric inhibitors that bind outside the
ATP-site would circumvent this mode of resistance, filling an unmet clinical need. This UMN-PP partnership
translates decades of biophysics research by two world-leading experts – Levinson and Thomas – toward drug-
discovery by resolving ligand-driven allostery in kinases. This is enabled by the FLT-PR instrumentation and
know-how required to implement nanosecond FLT detection in assays that resolve allosteric inhibitors in true
HTS mode. This overcomes key drawbacks of conventional kinase inhibitor screens, which detect kinase
inhibition or binding without regard to allosteric mechanism. The platform is broadly applicable, as almost all
kinases undergo the large-scale allosteric structural changes our technology detects. Success of this
project will catalyze adoption of this technology targeting a wide range of biomedically important kinases, as
highlighted by Photonic Pharma’s successful partnership with Bristol-Myers Squibb on drug discovery for other
high-priority therapeutic targets.

Public health relevance
Project Narrative This project merges the expertise and knowledge of its academic and industrial partners to develop and deploy novel drug discovery technology for identifying allosteric kinase inhibitors with primary applicability in oncology. Allosteric kinase inhibitors represent exciting next-generation cancer therapeutics that circumvent many of the limitations of current ATP-competitive kinase inhibitors.